Epigenetic mechanisms of stress and age-related cognitive decline

Project Summary/Abstract. Dysfunction of the hypothalamic-pituitary-adrenal axis, the major neuroendocrine
system regulating physiological responses to stress, is a common feature of older individuals with memory loss,
including those with Alzheimer’s disease. Indeed, accumulating effects of stress and glucocorticoid exposure
across the lifespan are presumed to contribute to age-related memory loss and enhance susceptibility to
Alzheimer’s disease via deleterious signaling alterations in glucocorticoid receptor-expressing neurons residing
in the medial temporal and frontal lobes that support normal memory. Neural activity in the hippocampus, which
supports declarative memory, or the prefrontal cortex, a region that is indispensable for working memory,
requires a fine balance between persistent excitation of glutamatergic, pyramidal neurons and competitive
inhibition provided by GABAergic interneurons. Recently published and preliminary findings from our laboratory
indicate that memory loss observed in aging or following chronic stress is mechanistically linked to altered
signaling via ionotropic NMDA receptors and metabotropic GABAB receptors in these brain regions. These
similarities suggest a common mechanism contributes to memory loss in chronic stress and aging and, by
extension, stress may interact with aging to increase severity of memory loss and susceptibility to age-related
neurodegenerative disease. Our long-term goal is to understand the molecular mechanisms that translate
stressful experiences into lasting changes in neural function that contribute to memory loss across the full
lifespan and, in so doing, identify new targets that will lead to the development of therapeutics that protect or
restore memory in older individuals. This project will use a rat model of age-related memory loss to test the
hypotheses that 1) stress increases vulnerability to memory loss across the lifespan via DNA methylation that
durably modifies transcriptional activity of genes that encode for synaptic proteins and 2) that stress-dependent
molecular changes in the aged brain require signaling transduced by glucocorticoid and mineralocorticoid
receptors. Such findings would be significant because they will identify specific molecular bases that transform
experiential and physiological factors into impaired synaptic function and memory loss in later life and also
establish a critical foundation for developing new therapeutic approaches to both prevent and reverse age-
related memory loss. This proposal builds on the applicant’s long-standing scientific commitment to investigate
the neural basis for cognitive decline in aging and Alzheimer’s disease. Productive collaborations initiated in a
prior F32 award will be advanced and combined with new mentorship, affording significant technical and
conceptual training in cutting-edge molecular approaches and bioinformatics. The scientific knowledge, technical
competence, professional skills and original data cultivated under this K01 award will directly support the
applicant’s transition to an independent scientific career as a PI leading his own NIH-funded research program.

Public health relevance
PROJECT NARRATIVE. Census data predict that the numbers of Americans over the age of 65 will reach 84 million by 2050, so the determining the cause of age-related cognitive decline is a matter of pressing scientific, clinical and social concern. This research project will examine how chronic stress affects DNA structure and gene expression in the brain and influences memory throughout the lifespan. Findings from this study will improve our knowledge of the mechanisms that contribute to cognitive decline in aging and lead to new strategies that can prevent or reverse such impairments.